Path C The FDA's Cooperative Agreement Program for States and Territories to Implement a National Produce Safety Program.

The Arkansas Department of Agriculture (ADA) Produce Safety Program will continue the
implementation of the FSMA Produce Safety Rule as a PATH C applicant. The Program will maintain and
build upon all required objectives cited in the FDA's Cooperative Agreement Program for States and
Territories to Implement a National Produce Safety Program. Sprout inspections will not be conducted
by the ADA Produce Safety Program. As a PATH C applicant, the ADA has evaluated existing statutory
and regulatory authority related to produce safety and determined that the Department has the
authority to implement the Produce Safety Rule by the powers and duties granted to the State Plant
Board in A.C.A. 2-16-206-207: THE PLANT ACT - Title 2 Agriculture - Subtitle 2. Agronomy - Chapter 16
Plant Disease and Pest Control - Subchapter 2 -- Plant Act of 1917. Additionally, the ADA adopted the
Arkansas Produce Safety Rule; the Rule incorporates the most current revision of 21 CFR 112 by
reference. Copies of these can be found within the Program’s Project Plan; the Rule can also be found at
the following web address: https://www.agriculture.arkansas.gov/wp-
content/uploads/2020/09/Arkansas-Produce-Safety-Rule.pdf

Public health relevance
Project Narrative: The Arkansas Department of Agriculture (ADA) developed and implemented a comprehensive Produce Safety Program in the previous FDA Produce Safety Cooperative Agreement Program (PAR-16-137). The Program includes education, outreach, and technical assistance, and an intricate regulatory program comprised of inspections, compliance, and enforcement. The ADA will continue to build and advance the Program by accomplishing key milestones required of the objectives contained within the new CAP.